MNSOD ACETYLATION PROMOTES CANCER STEM CELL PHENOTYPES IN BREAST CANCER

PROJECT SUMMARY Aggressive phenotypes of breast cancer are characterized by increased capacity of evading immune surveillance and generating metastasis. Our groups recently described that metastatic breast cancer cells expressing high levels of acetylated superoxide dismutase 2 (SOD2K68Ac) accumulate mitochondria-derived reactive oxygen species (mtROS) and promote stabilization of hypoxia-inducible factor 2α (HIF2α), involved tumor aggressiveness. HIF2α also regulates genes associated with immune protection, including the programmed death-ligand 1 (PDL1) that is widely recognized as a molecule eliciting immune evasion in cancer cells. Hence, we propose to investigate (1) if accumulation of SOD2K68Ac promotes PDL1 upregulation via HIF2α in breast cancer cells; (2) if SOD2K68Ac/HIF2α promotes mammary cancer immune evasion and metastasis in vivo using mouse model; and (3) if there is a subgroup of women with breast cancer that exhibits SOD2K68Ac/HIF2α molecular signature correlating with high PDL1 expression and immunotherapy resistance. We expect to identify a new mechanism of cancer immune evasion that can be targeted to improve therapeutic approaches to treat aggressive phenotypes of breast cancer exhibiting SOD2K68Ac molecular signature. The proposed translational research will be conducted by Dr. Coelho under the mentorship of Dr. Marcelo Bonini (primary mentor), Dr. Leonidas Platanias (co-mentor) and Dr. Massimo Cristofanilli (clinical co-mentor). All mentors have exemplary records of scientific achievement, innovation and leadership in the translational pipeline of cancer therapeutics and diagnostics. In addition to the scientific goal of this application, we expect that Dr. Coelho will accomplish a multidisciplinary training in clinical research, leadership, writing and management essential to establish an independent career in cancer immunobiology.

Public health relevance
Cancer stem cells are a rare subpopulation of cells in tumors associated with treatment failure and metastatic recurrence. Targeting this subpopulation could lead to therapies with better odds of curing cancer patients, however it is still unknown how cancer stem cells originate or what are their vulnerabilities. This project is based on the finding of a molecular signature associated with metastatic/stem-like cells (MnSOD-Ac/HIF2α) validated by mechanistic studies that showed: (1) MnSOD-Ac promotes stem-cell characteristics in breast cancer; (2) The targeting of MnSOD or HIF2α reduces chemoresistance and the stem-cell like subpopulation. Hence, this study is focused on determining the mechanisms linking the accumulation of MnSOD-Ac to stemness reprogramming as well as if MnSOD-Ac, MnSOD-Ac-derived reactive oxygen species or HIF2α are mechanistic therapeutic targets. Finally, if women with breast tumors displaying a MnSOD- Ac/HIF2α molecular signature are at increased risk of failing conventional treatments and/or developing metastatic disease. (The abbreviation MnSOD-Ac refers to manganese superoxide dismutase acetylated on lysine 68)